Immune response and viral dynamics within the female genital tract during hyperacute and acute HIV infection

Project Summary
HIV remains a global epidemic and, in the areas of greatest prevalence, disproportionately infects young
women. However, most studies of hyperacute and acute HIV infection of the female genital tract (FGT) are
conducted in in vitro, ex vivo, or nonhuman primate (NHP) models due to practical and ethical concerns. Because
of this, the immune response to HIV in the human FGT during the earliest stages of infection is largely undefined
and the degree to which current model systems recapitulate the events of natural infection is unclear. Critically,
the first cells to be infected following natural HIV infection of the FGT remain unidentified, creating a major hurdle
toward the development of interventions effect at preventing infection. The FRESH (Females Rising through
Education, Support, and Health) cohort in KwaZulu-Natal, South Africa, is a long-running program that is
designed to identify natural, hyperacute HIV infection and collect a variety of samples in a longitudinal manner,
presenting an unprecedented opportunity to examine the immune and viral dynamics of the FGT during
hyperacute and acute HIV infection. By utilizing cutting-edge transcriptomic techniques that have been validated
by our group, we will be able to elucidate the events within the FGT during this critical time period of infection.
Our overall hypothesis is that the FGT will have a strong inflammatory response that peaks earlier than the
systemic response in peripheral blood and that early inflammation will primarily be driven by antigen-presenting
cells (APCs), particularly plasmacytoid dendritic cells (pDCs), while CD4+ T cell subsets will bear the greatest
burden of genital infection. In the first Aim of this proposal, we will investigate the immune response to genital
HIV infection via population-level RNA sequencing using longitudinally collected bulk cellular population samples
from hyperacutely and acutely infected FRESH participants. We will also conduct a single cell transcriptomic
analysis of cells from the genital tract at the earliest time point following the detection of infection to investigate
which specific cellular subpopulations are responsible for inflammation and immune modulation. These analyses
will be supplemented by Luminex cytokine studies and immunofluorescence (IF) imaging of cervicovaginal
biopsy tissues from FRESH participants. In the second Aim, we will investigate the viral dynamics of hyperacute
genital HIV infection by identifying and visualizing infected cells using single cell RNA sequencing and tandem
in situ hybridization (ISH) and IF imaging. Additionally, we will examine the diversity of viral quasispecies present
in the FGT and in plasma at this time point to better ascertain the frequency with which local foci of infection in
the FGT successfully develop to establish systemic infection. The proposed studies will for the first time enable
a clear outline of key early immunological and viral events that occur during hyperacute and acute HIV infection
of the human FGT, allowing for the validation of existing experimental models and informing the development of
interventions to prevent HIV infection and spread.

Public health relevance
Project Narrative Despite being a primary site of infection, the human female genital tract remains largely uninvestigated in the setting of hyperacute and acute HIV infection. Utilizing unique samples obtained from the Females Rising through Education, Support and Health (FRESH) cohort, I propose to investigate both the immune response and viral dynamics that occur in the female genital tract following natural HIV exposure by leveraging RNA sequencing, microscopic imaging, and cytokine analysis techniques. This will provide new insight into HIV pathogenesis, allow for the validation of existing experimental models, and help to accelerate the development of therapeutic interventions.